RADIOLOCALIZATION OF IV MCA TO TAG-72 ANTIGEN IN COLORECTAL CANCER

Two monoclonal antibodies reactive against colorectal adenocarcinoma will be directly compared by simultaneous injection into patients with incurable colorectal cancer. The murine B72.3 will be tagged with 125-I while chimera B72.3 labeled with 131-I will be administered 5-10 days before laparotomy.